Investigating Molecular and Cellular Heterogeneity within the Human Kidney using Multimodal Imaging Approaches

PROJECT SUMMARY.
The chemical interplay within cellular networks facilitates diverse functions of organ systems and contributes to
human health and disease. The human kidney is a complex organ composed of an average of one million
nephrons that individually contain at least 26 distinct cell types. Nephrons then form a network consisting of a
glomerulus that is linked to various tubular segments, capillaries, lymphatics, and peritubular interstitial spaces.
This dynamic cellular network not only varies from one individual to another but throughout the kidney itself.
Because the kidney is responsible for waste management, electrolyte balance, blood pressure control, and red
blood cell production, differences in cellular composition or chemistry can greatly impact efficiency or disease
progression. To date, there is not complete understanding of the natural variance in the numbers of specific cell
types nor their respective chemistries within the kidney. Even less is known about how these metrics relate to
sex and race. Here, we propose to use a combination of imaging mass spectrometry (IMS) and co-detection by
indexing multiplexed immunofluorescence (CODEX IF) to establish a baseline of what molecules and cellular
populations constitute a normal, healthy kidney as well as how these change as a function of specific patient
demographics. While understanding the cellular and molecular constituents of healthy kidney tissue is important
by itself, this knowledge has clear implications in the definition of different disease states and phenotypes, such
as diabetic nephropathy and organ failure. We predict accomplishing these tasks through two key aims: 1.
determine the molecular profiles of functional tissue regions (e.g. glomeruli, cortex, and medulla) within the
human kidney as the function of sex and race using imaging mass spectrometry and 2. investigate the
composition of cell types within the medulla, cortex, and renal pelvis as a function of these demographics using
CODEX IF. In brief, IMS allows visualization of hundreds to thousands of endogenous metabolites and lipids,
while CODEX IF labels cell types and structures at a higher plexity than traditional IF methods. Though both
approaches provide essential information on their own, we can synergistically combine the data to obtain
molecular profiles of individual cell types to better parse the chemical differences between regions of tissue and
human patients. Ultimately, there will be molecules that are detected within every tissue as well as cell
compositions that are conserved among all the assayed patients. Additionally, there will likely be rare molecules
or unique cellular profiles that differ from the average. Both events are essential for understanding heathy
function with a longer-term goal of determining how these similarities and differences contribute to disease
development and progression. While a large-scale project, I am aided by many scientific leaders (see letters of
support) who are invested in my success and the ultimate success of the project. Our team will build a
comprehensive chemical and cellular atlas of the human kidney with emphasis on sex and race.

Public health relevance
PROJECT NARRATIVE. The human kidney is an essential organ that functions by the active coordination of over twenty-six cell types, organized into complex structures, such as glomeruli and tubules. Progression from healthy to diseased tissue can result from a chemical or cellular imbalance; however, there is a disparity in knowledge of how disease progresses on an individual basis. As such, we are performing a combination of imaging mass spectrometry and multiplexed immunofluorescence to explore the factors intrinsic to a healthy kidney, particularly in relation to sex and race, so that we can explore how these differences contribute to the development and progression of human disease.